Methods Core C

SUMMARY – CORE C
The Statistics and Networks Methods Core (Core C) of this PPG will actively collaborate with each of the
projects by helping them use statistical, network, and computational methods in their research; by advancing
statistical and network methods to expand the scope of their accomplishments; and by helping them solve any
unexpected problems that arise. Core C staff will collaborate with Project Leads on study designs, and will
supervise Core B programmers to overcome challenges and implement methods that Core C develops inside
the secure computing environment at The Dartmouth Institute, so that these can be used to analyze the patient
identifiable data relevant to each project. Motivated by the recent surge of interest in health and health care for
Alzheimer’s disease and related dementias (ADRD), a growing concern for health disparities and their
exacerbation by algorithmic bias, and advances in statistical methods and network analysis, Core C will
advance methods that will make all four projects more effective and impactful. Core C will focus on: (1)
statistical models for complex data structures that expand understanding of disparities and intersectional
disparities, (2) development of networks that better capture the structure of relationships linking physicians of
multiple specialties through the interdependencies in their medical practice, and (3) construction of novel
quality of care measures and models of network data. These methods will be applied to patients with claims-
based diagnoses of ADRD or who are at risk for developing ADRD. A common new theme in this renewal PPG
is the use of comparative-effectiveness research, as it overcomes bias and enhances statistical power to
quantify disparities and variations by modeling hierarchically structured and other forms of dependent data and
by forming inferences that are causally-defendable. Core C key personnel have made substantial progress in
establishing methods that use directional relationship information from patient-physician encounters in
Medicare claims to form innovative physician networks with directed edges. They will enhance this work by
using specialty and services-performed data to establish even more informative networks and network-based
measures of access to care and other important aspects of health care. Statistical models will also be devised
that use these networks to explain additional variation in outcomes and disparities, while longitudinal models of
the network itself will provide insights into trends in and the dynamic association of factors affecting ADRD
diagnosis and care. These innovations will allow the PPG-supported projects to delve deeper than would be
possible otherwise. Results and products (e.g., software) will be widely disseminated to research and
stakeholder communities. Core C will have a major supportive and innovative impact on the research of the
four projects and on the wider research communities working in ADRD, health disparities, and variations in
care with a goal of improving the U.S. health system.